Addressing Systemic Barriers Impacting Health in CHC Communities

ComPASS: Community-Led, Health Equity Structural Intervention Initiative (OT2):
Texas HOPE: Together Dissolving Food Insecurity Structural Barriers
Abstract
The Asian American Health Coalition of the Greater Houston Area dba HOPE Clinic and our
partners share the mission of health and wellbeing equity for everyone without prejudice. In our
proposal, “Texas HOPE: Together Dissolving Food Insecurity Structural Barriers,” we declare our
commitment to ending food insecurity, an intractable harm endured by our most vulnerable and
marginalized families and individuals. In our study region, Texas’ greater Houston area,
approximately 695,310 individuals endure food insecurity, including 1 in 5 children. Food
insecurity disproportionally impacts disadvantaged groups, who represent 80% of the population
in our areas: 45% Hispanic, 23.5% Black, and 12.2% Asian American or Pacific Islander. Using an
authentic community engagement participatory process, we will establish a CHESI Collaborative
of partners and use the Precede Proceed approach to plan and develop our structural
intervention CHESI study. Together, will we engage stakeholders and those with lived experience
to provide their perspectives and insight on food insecurity structural barriers, complete a
community assessment, and consider interventions. Concurrently, the CHESI Collaborative will
devise a sustainability plan that will ensure the intervention persists. With our local HERA, we will
compile multisource evidence, examine intervention options, and identify health and wellbeing
measures most influenced by food insecurity. The CHESI Collaborative will again reach out to our
community, garnering input on the draft intervention and implementation plan. Community
involvement will provide pivotal insight on considerations and potential challenges for the
successful rollout of the intervention. In preparation for Phase 2, HERA will devise a rigorous
research methodology that best suits the intervention.